Disease Modeling Unit

PROJECT SUMMARY DISEASE MODELING UNIT
The goal of the Disease Modeling Unit (DMU) of The Jackson Laboratory (JAX) Center for Precision Genetics
(JCPG) is to advance understanding of the mechanisms of disease pathobiology, and to provide robust platforms
to test novel therapeutic interventions, through the design, creation, and phenotypic validation of complex in vivo
models of human disease. Our DMU pipeline offers first-in-class genome editing technology and phenotyping
expertise, and managed access to the full spectrum of JAX services, resources, and know-how. Key innovations
of the DMU include use of humanization to enhance the translatability and construct validity of our models; strong
capabilities in complex allele design and engineering that can support study of mutations with different functional
consequences; resources and experience utilizing diverse genetic backgrounds when necessary and/or
appropriate, supported by tools developed by the Bioinformatics Core; and access to high efficiency
CRISPR/Cas9 genetic engineering technology. These innovations complement JAX’s exceptional behavioral,
genomic, and molecular phenotyping capabilities, its institutional scale, and its expertise and commitment to
supporting the Center’s mission. Over the current funding phase, the JCPG and the DMU have made enormous
progress towards our goal, generating 69 confirmed alleles for 33 individual disease conditions, with several
more in the pipeline. A majority of these alleles are complex, including many that incorporate extensive
humanization and/or conditionality to enhance their translational potential. The large number of nominations and
projects has allowed us to refine and focus our phenotyping into a discrete number of efficient phenotyping
packages that reflect the common features in certain disease categories, while adding molecular phenotyping
modalities to provide deeper insights into disease mechanisms and to identify disease biomarkers. We have also
incorporated novel platforms and technologies developed as part of our demonstration projects in the previous
cycle, including our F0 modeling platform that allows for rapid and cost-effective corroboration of novel variant-
phenotype associations. We will continue to deploy JAX’s collection of cores and resources into a single, flexible,
and cohesive disease modeling pipeline that can support the growing and diverse needs of the scientific and
rare disease communities. The Aims of the DMU are: To deploy our sophisticated and large-scale precision
model engineering capabilities to build advanced precision mouse models of rare disease in continued support
of external nominations from the rare disease and scientific community (Aim 1); To characterize new models
using an extensive and customizable phenotyping pipeline to uncover mechanisms of disease pathobiology and
to credential new models for preclinical/co-clinical testing (Aim 2); and To apply a novel, high-throughput F0
modeling platform for rapid interrogation of novel disease-associated variants in the mouse (Aim 3).